Pelvic Floor Disorders Network Data Coordinating Center: (2016-2021)

PFDN BioLIFT Supplement Abstract RTI serves as the data coordinating center (DCC) for the NICHD Pelvic Floor Disorders Network (PFDN) in support of its mission to improve the care of women with pelvic floor disorders by conducting well designed multicenter studies to inform diagnosis, prevention, and treatment. We provide the Network with statistical leadership in study design and data analysis and operational support through data management and logistical services. Specifically, we (1) collaborate in developing, implementing, and monitoring Network protocols; (2) provide data management, including preparation of public data files; (3) prepare reports including safety reports for the Data and Safety Monitoring Board; (4) collaborate in the analysis of data and publication of study results; (5) coordinate manufacturing of study drugs and placebos, acquisition of study equipment and materials, and collection and transport of biological specimens; and (6) provide all other support, including management of capitation payments to clinical sites, and logistical coordination of meetings and communications necessary to run an efficient and productive Network. Page 1 of 1

Public health relevance
PFDN BioLIFT Project Narrative The PFDN was established in 2001 to improve the care of women with pelvic floor disorders by conducting well designed multicenter studies to inform diagnosis, prevention, and treatment. A qualified, experienced data coordinating center is critical in helping the PFDN optimize research productivity through effective study design, implementation, data collection, quality assurance, monitoring, and statistical analysis. RTI will continue to provide multidisciplinary expertise to support high-impact collaborative research studies and provide communications and logistical support to optimize the efficiency and productivity of the Network. Page 1 of 1